Identifying individuals at risk of progression to active tuberculosis

Project Summary
Almost 2 billion people are infected with Mycobacterium tuberculosis (Mtb), the causative agent of tuberculosis
(TB). Approximately 10% of these individuals will progress to active TB disease over their lifetimes, but there is
currently no clinical test to distinguish those that will progress to active TB disease, from those that will not. If
we are to realize the World Health Organization's (WHO) goal of a world free of TB by 2035, the massive
reservoir of TB infection must be addressed with a cost-effective, ethical therapy for preventing progression,
based on treating only those most likely to progress. A diagnostic test that can accurately predict the risk of
progression is critical for treating these high-risk individuals and the eradication of TB. Our goal is to develop
such an assay. Our central hypothesis is that five independent host immune biomarkers, combined into a
single multimetric signature will predict progression from latent to active TB with at least 90% sensitivity and
specificity. We will test this hypothesis and achieve our goal by implementing the following specific aims: Aim
1: Compile a comprehensive dataset of biomarkers in a prospective cohort of individuals who are at risk of
progressing to active TB. Working with the Moldova Ministry of Health's National TB Program, we will enroll
3,685 close contacts of active TB cases. All participants will be followed for two years to determine who
progresses to active TB. We expect to identify ≥ 140 progressors. We will assess three previously established
blood-based predictors of active TB progression, and two novel assays. We will verify the performance of
previously published biomarkers in this population to discriminate progressors from non-progressors and
identify new candidate biomarkers using RNA-Seq of antigen stimulated PBMC and detection of Mtb-peptides
by NanoDisk MS. Aim 2: Use a discovery set of samples to develop predictive models of progression to active
TB. Using data from 140 progressors and 140 non-progressors from Aim 1 we will (1) Verify the performance
of existing biomarkers, (2) Use a cross-validation to identify new candidate biomarkers, and (3) derive
predictive models using logistic regression and machine learning methods to identify optimal biomarker
signatures that best predict progression to active TB within 12 months. Aim 3: Verify the ability of the model to
predict progression to active TB disease. Using the same approach as Aim 1, we will enroll a new set of 1,340
household contacts of active TB and identify at least 60 progressors and 60 matched non-progressors and
verify clinically the sensitivity/specificity of our models and biosignatures (Aim 2) to predict progression to
active disease. A combined host biomarker signature that can predict TB progression from a small blood
volume will have significant impact on the WHO End TB Program.

Public health relevance
PROJECT NARRATIVE Almost 2 billion people are infected with Mycobacterium tuberculosis, the causative agent of tuberculosis (TB). Approximately 10% of these individuals will progress to active TB disease over their lifetimes, but there is currently no test to distinguish those that will progress from those that will not. We propose to develop a multimetric signature of host biomarkers that together will have a sensitivity and specificity of ≥ 90% for predicting progression to active TB in one year, a critical first step to developing cost-effective and ethical treatment plans in order to reach the World Health Organization goal of Ending TB by 2035.